RACE, COVID-19, and Health Outcomes Among Individuals Born Preterm

ABSTRACT This project addresses a critical gap in the understanding of potential links between race, the COVID-19 pandemic, and the well-being of children. We will evaluate these relationships by collaborating with other ECHO cohorts, thus increasing the geographical variation of our study sample. Our cohort, derived from the Extremely Low Gestational Age Newborn (ELGAN) study, provides the opportunity to evaluate relationships within subsets defined in terms of gestational age at birth. Given the high prevalence of early life adversities among individuals born extremely preterm, we anticipate finding increased vulnerability to the harmful effects of the COVID-19 pandemic. Although fewer children than adults have developed life-threatening infections due to COVID-19, the public health policies implemented to stop the spread of COVID-19 have disrupted children’s lives through economic depression, social distancing, and unprecedented educational disruptions. The shift to distance learning has changed children’s home, school, and social environments, but we know very little about the impact of these changes on children’s health and development. These disruptions may have stronger negative effects on historically underserved groups, including lower income families, as well as racial and ethnic minorities. This proposal seeks to evaluate the unintended psychosocial impacts of COVID-19 public health policies on children and families, and to examine if these effects are more prominent within lower income communities and communities of color. We examine if COVID-19 Health Policies impose more hardships on families within these groups, and if these hardships adversely affect their positive health development, as indexed by academic competence and well-being. By collaborating with cohorts comprised primarily of children born near or at term, we will also evaluate whether COVID-19 related stressors have greater impact on a particularly vulnerable group of children, i.e., those born extremely preterm. Further, we will examine if school practices related to distance learning and supportive social networks are also associated with child outcomes, independent of COVID-19 hardships. This project will identify processes by which public health policies influence families and will identify practices that promote children’s positive health development.

Public health relevance
NARRATIVE In a cohort of adolescents born extremely preterm (before 28 weeks of gestation) we will evaluate relationships among race, the COVID-19 pandemic, and the well-being of children. We will obtain residential address to use for mapping of neighborhood level exposures, questionnaires to ascertain COVID-19 related stressors, and measures of child health and well-being, as reported by parents and their adolescent children. This project will identify processes by which public health policies influence families and will identify practices that promote children’s well-being during the COVID-19 pandemic.